The Role of Iron In Pulmonary Fibrosis

PROJECT SUMMARY
Idiopathic pulmonary fibrosis (IPF) is a chronic lung disease with a median survival of 3 years after diagnosis.
There are no cures for this disease. Although the etiology is still unclear, one of the major risk factors associated
with IPF is inhaled iron-rich particulate matter, such as asbestos and cigarette smoke. However, the specific role
of iron in the pathogenesis of IPF is an understudied area. The long-term goal of this project is to elucidate the
pathogenesis of IPF and thus to advance the development of effective therapies. The objective of the current
application is to understand the contribution of iron to the pathogenesis of IPF and the underlying mechanisms
with a focus on the iron-mediated activation of lung fibroblasts.
There is evidence showing that iron accumulates in the lung and contributes to lung fibrosis. However, the
molecular mechanisms for both processes are unclear. Our preliminary studies have identified the iron export
gene solute carrier family 40 member 1 (SLC40A1) as a key gene for iron accumulation in lung fibroblasts. We
have also identified two novel iron-regulated genes, SH3 domain-containing ring finger 1 (SH3RF1), an E3
ubiquitin protein ligase, and homeodomain-interacting protein kinase 2 (HIPK2), a cotranscriptional regulator and
provided evidence that both genes regulate lung fibroblast activation. Based on our preliminary studies, our
overall hypothesis is that an elevated level of iron in lung fibroblasts due to reduced SLC40A1 leads to the
activation of lung fibroblasts via the downregulation of SH3RF1 expression and the upregulation of HIPK2
expression. The hypothesis will be tested by a combination of in vitro studies using primary human lung
fibroblasts and in vivo strategies in two mouse lung fibrosis models using pharmacological and genetic
interventions. Aim I will determine the mechanisms by which iron accumulates in lung fibroblasts via SLC40A1
and the regulation and functional roles of SH3RF1 in iron-mediated lung fibroblast activation using loss- and
gain-of-function and mutagenesis approaches. Aim II will define the mechanisms by which iron activates lung
fibroblasts via HIPK2 using gene manipulation, coimmunoprecipitation, ubiquitination and molecular signaling
pathway analyses. Aim III will determine the in vivo effects of iron and HIPK2 on lung fibrosis in two preclinical
mouse models of bleomycin- and asbestos-induced lung fibrosis using fibroblast-specific genetic deletion of
Hipk2 and pharmacological inhibitors. The proposed studies will establish the molecular mechanisms of iron
accumulation in lung fibroblasts and novel roles for SH3RF1 and HIPK2 in lung fibroblast activation.

Public health relevance
PROJECT NARRATIVE Idiopathic pulmonary fibrosis (IPF) afflicts approximately 3 million individuals worldwide, and an estimated 40,000 people succumb to the disease each year in the United States. Achieving the goals of this project will lead to the discovery of new molecules and pathways that modulate fibroblast activation and thus provide insights toward the development of effective therapies for IPF.